Ultra-High Field Translational MRI Scanner

Project Summary
This High End Instrumentation grant proposal seeks to replace the 7T MRI scanner that is currently operational
at the Lucas Center for Imaging (LCI) at Stanford University. The aforementioned scanner was one of the first
installed in the USA and been operational since 2006. Recently, the serviceability of this system, as well as
that of others sharing the same cryostat design, has been severely limited by the termination of this line of
products by their former manufacturer (Agilent Technologies, which had bought Magnex Scientific, the original
designer and service provider for the magnet). The proposed system will be provided by Siemens Medical
Systems, which now manufactures and services its new generation of actively shielded 7T magnets. In
addition, this new system is based on an FDA-approved platform, which will lessen the burden on patients
participating on our clinically driven research projects.

Public health relevance
Project Narrative This proposal will provide funds for replacing the 7T whole-body MRI human scanner at the Lucas Center for Imaging (LCI) at Stanford University. This scanner is an essential tool for several NIH-funded grants that are currently hampered by the limitations of the existing system and its limited serviceability. The proposed replacement will resolve reliability challenges with the existing legacy system, address service life issues, and decrease patient burden.